Understanding Frontotemporal Dementia Using Drosophila and iPSC Models

ABSTRACT
Dementia in aging populations poses a major global health challenge in years to come. In addition to Alzheimer’s
disease (AD), frontotemporal dementia (FTD) is another major form of presenile dementia caused by focal
degeneration of the prefrontal and/or temporal lobes. FTD patients show changes in personality, social
behaviors, or language production. Currently, effective treatments for FTD still remain elusive and the underlying
pathogenic mechanisms are poorly understood. The identification of many genes whose mutations are
associated with FTD offers an exciting entry point. Among them a GGGGCC (G4C2) repeat expansion in the first
intron of C9ORF72 is the most common cause of FTD. This mutation is also the most common genetic cause of
amyotrophic lateral sclerosis (ALS), further highlighting the importance of understanding neurotoxicity caused
by expanded G4C2 repeats and dipeptide repeat (DPR) proteins translated from both sense and antisense repeat
RNAs. In this proposal, we will take advantage of both classical genetics of fruitfly Drosophila and cutting-edge
techniques that are applicable to patient neurons differentiated from induced pluripotent stem cells (iPSCs) to
identify and characterize potent genetic modifiers of disease phenotypes relevant to C9ORF72-FTD/ALS. These
mechanistic studies will help understand molecular pathways involved in these disorders and may also reveal
potential effective drug targets for therapeutic interventions.

Public health relevance
Narrative Frontotemporal lobal degeneration (FTLD) is a leading cause of dementia and the underlying molecular pathogenic mechanisms are largely unknown. Multidisciplinary approaches—including molecular, cellular and genetic analyses in fruitfly Drosophila and patient-specific induced pluripotent stem cells (iPSC)-derived cortical neurons—will be used to identify and investigate novel molecular pathways that can modulate disease phenotypes. If successful, these studies will identify new molecular targets and pathways for therapeutic development for frontotemporal dementia (FTD) and related neurodegenerative disorders.